Behavioral or Solifenacin Therapy for Urinary Symptoms in Parkinson Disease

The number of persons with Parkinson Disease (PD) in the United States is expected to double by 2030 as the
population ages. Importantly, this increase in the prevalence of PD will have greater impact within the
Department of Veterans Affairs (VA) because the Veteran population is older than the general population and
Veterans with PD are more likely than those without PD to rely solely on VA for their health care. While PD is
often characterized by the motor symptoms of the disease (tremor, bradykinesia, rigidity), non-motor symptoms
such as urinary symptoms correlate more closely with impaired well-being as the disease progresses.
However, the impact of urinary symptoms in PD extends beyond worsened well-being. The urinary symptoms
of overactive bladder (OAB), including urgency, frequency, and nocturia, with or without urinary incontinence,
are the most common urinary symptoms of PD. OAB symptoms are associated with falls (a cause of
increased mortality in PD), with spouse/caregiver stress, and, ultimately with institutionalization, thus it is
critical that we optimize the care of urinary symptoms for Veterans with PD.
Several studies suggest abnormal central nervous system processing of sensory input from bladder
afferent nerves contributes to OAB symptoms in PD, possibly because of delayed recognition of bladder
fullness. This mirrors findings in non-PD populations with OAB. In the non-PD OAB population, pelvic floor
muscle contractions diminish bladder muscle contraction and recent evidence demonstrates that behavioral
training with pelvic floor muscle exercises improves the cortical integration of bladder afferent signals. Pelvic
floor muscle exercise-based behavioral therapy for OAB symptoms requires individuals to learn a motor skill
and implement an adaptive behavioral strategy to delay the need to void. Because of its effectiveness
compared to drug therapy, pelvic floor muscle exercise-based behavioral therapy is recommended first-line in
men and women with OAB who do not have PD. However, the most recent clinical guidelines for the treatment
of urinary symptoms in PD recommend treatment with anticholinergic drugs. While some anticholinergic drugs
are effective in reducing symptoms of OAB, it is important to note that there is a glaring lack of an empirical
evidence base to promote these drugs in the setting of PD given that they add to the anticholinergic burden of
antiparkinsonian therapy, and may worsen the cognitive and autonomic burdens of the illness. Therefore,
randomized controlled trials (RCTs) are needed to optimize treatment paradigms for urinary symptoms in PD.
We propose a three-site, RCT conducted at the Atlanta (lead site), Birmingham and Richmond VA's to
establish non-inferiority of pelvic floor muscle exercise-based behavioral therapy compared to drug therapy for
OAB symptoms in adults with PD. Groups will be stratified by OAB symptom severity, PD motor symptom
severity, gender, and site. We will randomize 90 participants in order to complete the study in 80 participants,
assuming 85% power and a non-inferiority margin for the OAB symptom score of 15% at 12-weeks. The
primary outcome measure will be urinary symptom severity as measured by the International Consultation on
Incontinence Questionnaire(ICIQ)-OAB symptom score collected at 3 time points during the study: baseline, 6
weeks, and 12 weeks. Our benchmark for successful treatment will be a ≥ 2 point reduction in the ICIQ-OAB
symptom score, which corresponds with perceived benefit in preliminary studies of behavioral therapy
treatment for OAB symptoms in PD. To evaluate the primary efficacy outcome, we will utilize a random effects
mixed model and adjust for baseline OAB symptom score severity. Additionally, in order to better understand
central control mechanisms of bladder function, we will determine if domain-specific cognitive function impacts
the response to exercise-based behavioral therapy or drug therapy for urinary symptoms. At baseline and 12
weeks, randomized participants will undergo a brief neuropsychological battery. Understanding how domain-
specific cognitive function impacts response to treatment may inform new targets for rehabilitation therapy.

Public health relevance
The impact of urinary symptoms in Parkinson disease (PD) extends beyond worsened well-being. Urinary symptoms common in PD, especially incontinence and nocturia, are major risk factors for falls likely due to the combination of urinary urgency and impaired mobility (and falls are a leading cause of mortality in PD), for spouse/caregiver stress due to decreased mutuality in the relationship, and for institutionalization, largely due to increased disability. Additionally, most medications currently recommended for urinary symptoms in PD are anticholinergic and have the potential to worsen the progressive cognitive and autonomic burdens of the disease. Veterans with PD are also more likely to rely solely on VA for their health care than Veterans without PD. Thus, optimizing the care of urinary symptoms for Veterans with PD becomes imperative, particularly for VA. Using a non-inferiority design, this proposal seeks to demonstrate the comparative effectiveness of pelvic floor muscle exercise-based behavioral therapy versus drug therapy to treat urinary symptoms in PD.